Flow Cytometry Core

Project Summary
The Aim of the Flow Cytometry Core is to provide access to state-of-the art flow cytometry (sorting and
analysis) for all the members of the Oklahoma Anthrax Group (U19). The Flow Cytometry Core has two high
speed fluorescence activated cell sorters (Beckman-Coulter MoFlo XDP and BD FACSAria) and three
analyzers (FACSCalibur, FACSCelesta and LSRII, all from BD). Dr. Linda Thompson, who is an expert in
multicolor analysis and sorting of human lymphocytes, will serve as Core Director and technical assistance will
be provided by Mr. Jacob Bass and Dr. Diana Hamilton. Mr. Bass and Dr. Hamilton will perform all the sorts.
Funds for the purchase of monoclonal antibodies and user fees will be provided to all COBRE participants. All
three research projects depend upon flow cytometry to accomplish their scientific goals. Thus, this Core will be
heavily used and is critical for the success of the Oklahoma Anthrax Group.